Advancing mycobacteriophage aerosol for prevention of pulmonary infections

PROJECT SUMMARY/ABSTRACT
Pulmonary bacterial infections account for a staggering amount of morbidity and mortality worldwide, particularly
from Mycobacterium tuberculosis (Mtb). Furthermore, drug resistant strains of Mtb are emerging at an alarming
rate, making antibiotic-based control of these epidemics less productive. Alternative intervention strategies that
prevent infection or synergize with antibiotic treatments would have a major impact on the global disease burden
by interrupting transmission. In particular, healthcare workers, household contacts of individuals with active
disease and immunocompromised individuals are disproportionally at higher risk of infection due to elevated
pathogen exposures and weakened immune systems, respectively. We hypothesize that a focused pre- or
post-exposure prophylaxis strategy using aerosol delivery of lytic mycobacteriophage may provide
sterilizing protection in these high-risk populations and offer a more immediate solution while efficacious
anti-mycobacterial vaccines are being developed. Bacteriophage (phage) have been minimally used in
emergency clinical applications for skin and soft tissue infections and disseminated bacterial infections, but not
to-date as an aerosol strategy against pulmonary mycobacteria. One limitation in the field preventing these
advancements is the availability of a reproducible preclinical model of aerosol phage delivery that can be
leveraged for efficacy testing. Importantly, our preliminary proof-of-concept results suggest that aerosol delivery
of phage to mice can significantly reduce bacterial burden after challenge with Mtb. In order to advance aerosol
phage delivery, in Aim 1 we will refine our preclinical model to alleviate this limitation by leveraging commercially
available technology to reproducibly deliver phage as an aerosol. In Aim 1 we will leverage spray drying
technologies generate dry powder phage, with an emphasis on compositions that afford thermostability, and
evaluate the efficacy-limiting anti-phage or tolerogenic host immune responses generated after repeated phage
delivery. Aim 2 will be devoted to determining if high titer aerosol delivery of phage cocktails can effectively
prevent infection after pulmonary challenge with drug sensitive and drug resistant Mtb in a preclinical mouse
model and evaluating drug and phage synergy in vitro and in vivo. Completion of the Aims in this proposal will
lead to 1) the establishment of a novel reproducible system for aerosol delivery of phage, 2) lay the foundation
for dry powder product delivery (e.g. inhalers) that can reach more remote and resource limited areas of the
world, 3) provide translational scientific knowledge about host responses to mucosal phage delivery and lastly,
4) establishing preclinical efficacy against Mtb that will help advance aerosol phage delivery as a viable and
translational stop-gap for pulmonary bacterial transmission.

Public health relevance
PROJECT NARRATIVE Bacteriophages represent a readily abundant biologic tool to leverage against pulmonary infections with Mycobacterium tuberculosis. A translational preclinical methodology of aerosol bacteriophage delivery partnered with a bacterial challenge efficacy model would help advance this prevention of infection strategy. Short term, these focused advancements will help mitigate transmission of mycobacteria in vulnerable populations, which in the long term are predicted to have great impact on these epidemics and would help meet the global initiative to End Tuberculosis.